Administrative Core

SUMMARY ADMINISTRATIVE COMPONENT
The Administrative Core comprises a team of faculty and staff who will work together to oversee the research,
training, planning, and outreach activities of the Center. The multidisciplinary, inter-institutional nature of our
proposal not only places a premium on effective scientific management but also creates many opportunities for
collaboration with other organizations. Exploiting these opportunities is greatly facilitated by the structure of the
HMS Laboratory of Systems Pharmacology (LSP), in which the current proposal is based. The LSP was
established in 2014 to support precisely the type of systems biology research proposed here and is split
~60:40 between laboratory and computational research.
Our management plan reflects the belief that effective application of Systems Biology methods to
understanding predictors of drug sensitivity and resistance in melanoma, brain cancer and breast cancer
requires the participation of investigators with diverse skill sets spanning computational biology, clinical
science, bioinformatics, systems biology, and statistical reasoning. The Administrative Core will support the
efforts of this team and assist students, postdocs and junior faculty in becoming future leaders in the systems
biology of cancer (Aim 1.1). The core will facilitate meetings of the different groups involved in experimental
design (Aim 4 Project 1; Aim 5 Project 2; Aim 6 Project 3) and measurement and analysis methods
executed by the Systems Pharmacology Core (Aim 2). It will also organize an External Advisory Committee
(Aim 1.2), coordinate Center Pilot grants (Aim 1.2) and develop a Website to share information on the
activities of the Center (Aim 1.1) and to distribute its results and data. The administrative core will monitor the
overall scientific progress of the Center and evaluate the Center's scientific achievements using general and
project-specific metrics (Aim 1.3). Finally, the Core will also support the efforts of the Center in outreach
activities including website development, training, and future collaborations with visiting scientists (Aim 1.1).
The plan described herein will ensure effective communication and interaction among investigators within the
Center and with the NCI and other Systems Biology Centers.